Improving pediatric brain tumor treatments using FLASH radiotherapy

PROJECT SUMMARY
Our R01 application entitled, “Improving pediatric brain tumor treatments using FLASH radiotherapy” is
focused on translating a novel irradiation modality into clinical practice. Here we will test whether radiation
delivered in ultra-high dose rate (one-tenth of second), which far exceed the dose rate used in current clinical
practice (minutes), can significantly reduce normal tissue toxicities associated with the radiotherapeutic
management of childhood medulloblastoma (MB). The overarching goal is to alleviate the long term
neurocognitive and cerebrovascular complications that compromise the quality of life of MB survivors while
maintaining tumor control. To achieve these goals, we will undertake studies using clinically relevant FLASH
and conventional radiation regimens. Two distinct human MB tumor models will be orthotopically implanted
in the brain of nude mice to investigate simultaneously tumor response and neurocognitive function after
irradiation. In addition, for long-term follow up, tumor-free mice will also be subjected to cranial irradiation
using FLASH or conventional dose rate irradiation. Short-term (1-month) and longer term (4-6 months) studies
conducted on tumor bearing and tumor free mice respectively, will critically evaluate tumor control,
neurocognitive, cerebrovascular and molecular outcomes in these cohorts. Preclinical studies investigating the
response of MB tumors, behavioral performance on multiple learning and memory tasks, vascular structure and
integrity and the sparing of the neurogenic niche will unambiguously elucidate many of the mechanisms
underlying the neuroprotective effects of FLASH radiotherapy. Data derived from these collaborative studies
between UCI and the CHUV will facilitate the clinical translation of FLASH-RT to pediatric oncology, where
despite the favorable prognosis of children diagnosed with MB, survivors still suffer a lifetime of complications
caused by their prior radiotherapy, a scenario we hope to ameliorate with our innovative FLASH technology.

Public health relevance
PROJECT NARRATIVE Radiotherapy remains a frontline treatment for childhood medulloblastoma (MB) where long-term survival in the majority of patients (> 80%) is accompanied by debilitating cognitive and cerebrovascular side effects. The proposed R01 seeks to evaluate the benefit of FLASH for the treatment of MB, a new ultra-high dose rate radiation modality that greatly minimizes normal tissue toxicities without compromising the eradication of brain tumors when compared to conventional dose rate radiation protocols currently used in the clinic. This project involves studies approximating clinical treatments of MB using a relevant grade 3 MB tumor orthotopically implanted in the brain of mice as well as tumor free animals. Mice subjected to each radiation modality will be evaluated at short (1-month) and long-term (4-6 month) post-irradiation times for tumor control, neurocognitive, cerebrovascular and molecular outcomes to provide clinical and mechanistic insight into the neuroprotective effects of FLASH.